VARICELLA-ZOSTER VACCINE IN HEALTHY SEROPOSITIVE ADULTS

Evaluate the safety and tolerability of six vaccine formulations containing varying quantities of infectious virus in healthy seropositive adults 60 years of age of order. Assess varicella-zoster virus specific cell mediated immune responses to each of the vaccine formulations.